EVALUATION OF GANCICLOVIR IN SYMPTOMATIC CONGENITAL CMV INFECTIONS

This is an investigation of the safety, tolerance and efficacious dosage of ganciclovir for administration to infants with congenital CMV disease in Phase I and Phase II trials, and Phase III trial now is enrolling and following subjects to determine impact of treatment on death, neuro development, and hearing loss.